Administrative Core

The Administrative Core will support the infrastructure of the Center as described in detail in "Organizational and Administrative Structure " in the Overview of this application. It will enable the smooth functioning of the Center by assisting the Center Director with the daily management of the Center. The Core will organize the meetings of the Steering committee, Center Investigators, and Internal and External Advisory Boards. The Core will assist the Center Director in reviewing progress and preparing reports. The Core will provide logistical support for the Center educational activities. The Core will aid in the dissemination of scientific information to Center investigators and to the scientific community, and provide logistical support for collaborations with other Centers and attendance to the annual Udall Center meeting. The Core will play an essential role in facilitating regular interactions between the Center and patient support and advocacy groups.